Survival and Recurrence of Dormant Cancer Cells

DESCRIPTION (provided by applicant): Recurrent breast cancer is typically an incurable disease. As a consequence, the propensity of breast cancers to recur following treatment is the most important determinant of clinical outcome. For many types of human cancer, residual tumor cells - referred to as minimal residual disease - remain following treatment that are not detected by conventional clinical testing. In the case of breast cancer, disseminated tumor cells are present in 20-40% of primary breast cancer patients lacking any clinical or histopathological signs of metastasis. These cells have the ability to survive in a presumed dormant state within tissues for up to 20 years, either as solitary cells or as micrometastases. Ultimately, residual cells re-emerge from this latent state and resume growth, leading to cancer recurrence. As such, minimal residual disease, tumor dormancy, and recurrence constitute fundamental manifestations of tumor progression that are responsible for the vast majority of breast cancer deaths. Despite the unrivaled clinical importance of these aspects of breast cancer progression, however, the mechanisms underlying them are largely unknown. Since dormant residual tumor cells constitute the reservoir from which recurrent cancers invariably arise, the lack of therapeutic approaches specifically targeted against these cells - as well as our lack of understanding about their biology-constitutes major obstacles to the successful treatment of human cancers. As such, the development of targeted therapies designed to block pathways on which residual tumor cells depend for survival and growth would represent an attractive approach to preventing cancer recurrence. To pursue this goal, we have developed and validated a series of doxycycline-inducible transgenic mouse models for MYC, HER2/neu, Wnt1, and Akt-overexpressing breast cancers that display key features of human breast cancer progression, including minimal residual disease, tumor dormancy, and recurrence. In this application, we will use these models to elucidate the molecular pathways that contribute to tumor dormancy and recurrence. The specific aims of this application are to determine the role of the c-Met and Fbw7/Notch pathways, in mammary tumor dormancy and recurrence. Our preliminary data suggest that each of these pathways may promote the survival and recurrence of dormant residual tumor cells. Reducing breast cancer mortality will ultimately require a substantially improved understanding of minimal residual disease, tumor dormancy, and recurrence than currently exists. By probing these critical manifestations of breast cancer progression, the studies proposed in this application will advance the therapeutic goals of maintaining tumor cells in a dormant state or inducing their death by targeting their survival mechanisms. This knowledge could facilitate the development of more effective therapeutic approaches that would dramatically alter the treatment options available to millions of breast cancer survivors.

Public health relevance
PUBLIC HEALTH RELEVANCE: Residual breast cancer cells that survive therapy have the ability to survive in a dormant state following treatment and linger unrecognized for more than a decade before emerging as recurrent disease. Since recurrent breast cancer is typically an incurable disease, and since recurrent breast cancers typically arise from disseminated tumor cells, understanding the biology of minimal residual disease and elucidating the molecular pathways that contribute to tumor dormancy and recurrence is a critical priority in breast cancer research. This application is focused on that goal. Residual breast cancer cells that survive therapy have the ability to survive in a dormant state following treatment and linger unrecognized for more than a decade before emerging as recurrent disease. Since recurrent breast cancer is typically an incurable disease, and since recurrent breast cancers typically arise from disseminated tumor cells, understanding the biology of minimal residual disease and elucidating the molecular pathways that contribute to tumor dormancy and recurrence is a critical priority in breast cancer research. This application is focused on that goal. __SpecificAimsTextDelimiter__ RESEARCH PLAN Specific Aims Breast cancer is the most prevalent cancer and the leading cause of cancer mortality among women worldwide12. The natural history of human breast cancer is characterized by the progressive selection and outgrowth of cells that possess increasingly aggressive properties. Among these properties, the propensity of breast cancers to recur following surgery, radiation, and adjuvant therapy is the most important determinant of clinical outcome, since recurrent breast cancer is typically an incurable disease. For many types of human cancer, residual tumor cells - referred to as minimal residual disease - remain following treatment that are not detected by conventional clinical testing. In the case of breast cancer, disseminated tumor cells are present in 20-40% of primary breast cancer patients lacking any clinical or histopathological signs of metastasis13. These cells have the ability to survive in a presumed dormant state within tissues for up to 20 years, either as solitary cells or as micrometastases. Ultimately, residual cells re- emerge from this latent state and resume growth, leading to cancer recurrence. As such, minimal residual disease, tumor dormancy, and recurrence constitute fundamental manifestations of tumor progression that are responsible for the vast majority of breast cancer deaths. Despite the unrivaled clinical importance of these aspects of breast cancer progression, however, the mechanisms underlying them are largely unknown. Residual neoplastic cells constitute the cellular reservoir from which tumor recurrences invariably arise and thereby constitute a major obstacle to the successful treatment of human cancers. Accordingly, understanding the biology of residual tumor cells and elucidating the molecular pathways and cellular processes that contribute to tumor dormancy and recurrence is a critical priority in cancer research. These issues are the focus of this application. A particular difficulty in studying minimal residual disease, dormancy, and recurrence in breast cancer has been the challenge of identifying and isolating residual neoplastic cells in patients and the lack of animal models that recapitulate these key features of breast cancer progression. To address this critical gap, we have developed and validated a series of doxycycline-inducible transgenic mouse models for HER2/neu, MYC, Wnt1, and Akt-overexpressing breast cancers that display these key features of human breast cancer progression9-11,14,15. In this application, these models will be used to address fundamental questions regarding the biological properties of residual tumor cells, and the pathways that contribute to tumor dormancy and recurrence. The specific aims of this application are: Aim 1: Determine the role of the c-Met pathway in tumor dormancy and recurrence. The first aim of this proposal is based upon our observations that: the receptor tyrosine kinase c-Met is amplified and overexpressed in three different mouse models for breast cancer recurrence; the c-Met ligand, hepatocyte growth factor (Hgf), is up-regulated in recurrent mouse mammary tumors; the pro-survival protein, Ssb-1, which potentiates Hgf-induced c-Met signaling, is also up-regulated in recurrent mouse mammary tumors; activated levels of phospho-Met are up-regulated in recurrent mouse mammary tumors; and elevated levels of c-Met are associated with an increased risk of recurrence in women with breast cancer. Based upon these findings, we hypothesize that up-regulation of c-Met signaling promotes the survival and recurrence of dormant mammary tumor cells. This aim will use intact and orthotopic genetically engineered mouse models for tumor dormancy and recurrence to determine the functional contribution of the c-Met pathway to these processes. Aim 2: Determine the role of the Fbw7/Notch pathway in tumor dormancy and recurrence. Fbw7 is the substrate recognition component of the SCF-type ubiquitin ligase (SCFFbw7), which is required for Notch degradation. The second aim of this proposal is based upon our observations that: Fbw7 is down-regulated during mammary tumor recurrence in the mouse; decreased levels of Fbw7 are associated with an increased risk of recurrence in women with breast cancer; elevated levels of Notch1 are associated with an increased risk of recurrence in women with breast cancer; and mammary tumor recurrence in the mouse is inhibited by treatment of mice bearing residual tumor cells with gamma-secretase inhibitors. Based upon these findings, we hypothesize that down-regulation of Fbw7 promotes mammary tumor recurrence by inducing the up- regulation of Notch signaling. This aim will use intact and orthotopic mouse models for dormancy and recurrence to determine the functional contribution of the Fbw7/Notch pathway to these processes.